Implicit Word Learning in Code-switched Contexts by Bilingual Children with and without Developmental Language Disorder (DLD)

ABSTRACT
Bilingualism is common in many parts of the world and in the United States at least one-third of the population
under age five speaks a language other than English at home. While there is motivation for the use of both
languages in treatment for bilingual children with Developmental Language Disorder (DLD), it remains unclear
how to optimize the integration of two languages for learning. Code-switching, or the use of multiple languages
in discourse, is an especially controversial topic within bilingual language development, and the effect of code-
switching on language learning is not well understood. We aim to test the effect of code-switching on
bilingual children’s ability to learn novel words. Our target population is four- to six-year-old Spanish-English
bilingual children across the full range of language ability (from typical to weak skills in both languages, i.e.,
DLD). We will test learning via an implicit learning task, contrasting learning between single-language and code-
switched conditions. Specific Aim 1 is to examine the effect of code-switching on implicit novel word learning in
bilingual children with and without DLD across two time points (immediate and delayed). In two studies under
this aim, we will test the effect of code-switching on novel word learning, manipulating the placement of the
language switch across studies (prior to the novel word in Study 1; after the novel word in Study 2). Both studies
will test children immediately after learning and after a 10-minute delay. Specific Aim 2 is to examine the effect
of language ability on word learning in bilingual children with and without DLD. Across both studies, children’s
language skills will be assessed via an omnibus measure of language ability measuring language skills across
English and Spanish. Children with DLD are characterized by processing and learning difficulties; therefore,
children with lower levels of language ability might be especially sensitive to an effect of code-switching. At the
same time, children with DLD demonstrate more difficulty with initial encoding than with long-term retention of
information; therefore, children with lower levels of language ability may show different patterns of sensitivity to
code-switching at immediate vs. delayed testing. Specific Aim 3 is to examine the effect of code-switching
exposure on word learning in bilingual children. Across both studies, direct measurements of code-switching
exposure collected via naturalistic parent-child interactions will be used to test the association between code-
switching exposure and word learning in code-switched vs. single-language contexts. The proposed project will
contribute to the theoretical understanding of the word learning mechanisms in single- and dual-language
contexts, as well as to the broader lines of inquiry into the mechanisms that support code-switching in bilinguals.
These studies are the first to empirically test the effect of code-switched input on implicit word learning across
time points in bilingual children with DLD. Practically, the results may provide foundational information for
clinicians delivering services to bilingual children with DLD and to parents who raise them.

Public health relevance
NARRATIVE Bilingual children encounter language switching in their environments; however, it is unknown how such input affects language learning. This project will examine how code-switching affects word learning for Spanish- English bilingual children with and without Development Language Disorder (DLD), both short term and over time. This work will help inform clinicians, educators, and parents on best practices for bilingual children’s language learning and improve our understanding of the unique linguistic experience of bilingual children.